EFFECTS OF ACUTE TRYPTOPHAN DEPLETION ON MOOD AND FEEDING IN EATING DISORDERS

The aim of this study is to characterize serotonergic activity in anorexia and bulimia nervosa using a new technique that acutely depletes tryptophan which, in turn, should reduce CNS serotonergic activity.